Control of Cysteinyl Leukotriene Receptor Expression in

Peptidyl leukotrienes signal through at least two cysteinyl leukotriene receptors. The control of expression of these two receptors is not well understood. The current project will propose to study the effect of proinflammatory cytokines on gene and protein expression of both receptors in human cells. The structure of the two genes and of the 5' promoter region of each has been determined. Assays of gene expression, steady state mRNA expression, and cellular protein expression have been developed. Human cell lines which express either LTR1 or LTR2 are being studied. A manuscript is published, and a second manuscript has been submitted.